2012-Directed Differentiation of Stem Cells to Cardiomyocytes Using Optically Act

DESCRIPTION (provided by applicant): We propose a new technology for dynamic stem cell culture, using arrays of optically actuated polymer microposts. The polymer structures will be created by replica molding of straight and slanted microposts, made using carbon nanotube (CNT) and silicon master molds. The replica structures will be cast using photoactive liquid crystal elastomers (LCEs). Illumination of the LCE microposts will cause a rapid change in their shape and/or stiffness; and it will be possible to actuate arbitrary areas of posts based on the spot size and intensity of the illumination beam. We will assess cell viability on LCE structures i comparison to conventional poly- dimethylsiloxane (PDMS) structures as a benchmark material, by engineering the geometry and stiffness of the two materials. Using designed arrays of microposts enabling dynamic modulation of rigidity and strain that mimics the amplitude and force of cardiomyocyte beating, we will investigate pathways for mechanically-modulated differentiation of human embryonic stem cells (hESCs) into cardiomyocytes. Thus, we will aim to improve the accuracy and throughput of cardiomyocyte differentiation, and the understanding of how mechanotransduction affects cardiogenic differentiation. Successful development of this novel system would enable further research on mechanotransductive signaling under dynamic control, and possibly the realization of mechanically controlled assays for high-throughput cell culture. 1

Public health relevance
PUBLIC HEALTH RELEVANCE: Mechanotransduction is innate to the growth and function of cells and tissues, and to the pathology of disease. The novel optically actuated micropost array tool (OAPA) developed in this project will enable improvements in the speed and accuracy of stem cell differentiation, by combining mechanical and chemical factors in a dynamic cell culture environment. Experiments will focus on the targeted differentiation of cardiomyocytes for use in heart regeneration therapy, and the technology could be applied to many other cell types, via fundamental studies of cell behavior, and development of novel instruments for cell analysis and high-throughput differentiation. 1